CORE--CLINICAL DATABASE AND FOLLOWUP

The objectives of this Core are: 1. The establishment of a clinical database of subjects enrolled in the individual Projects. 2. The long term follow-up of all participants. 3. The standardization of questionnaires.